Mechanisms of Immune Dysfunction after Trauma and Surgical Sepsis

Project Summary/Abstract
Trauma and Surgical Sepsis are among the leading causes of morbidity and death worldwide. Both of these acute
insults can lead to immune dysfunction that then contributes to a state of persistent critical illness. This immune
dysfunction is manifested by an excessive systemic inflammatory response that can lead to organ dysfunction;
and a simultaneous suppression of immune defenses that renders patients susceptible to secondary infections.
However, we lack a comprehensive and integrated view of how humans respond to severe injury, and more
importantly, how these responses differ between patients that recover quickly vs. those that die and/or
development persistent critical illness. Advances in single cell multiomics and systemic multi-platform,
multiomics now makes it possible to characterize changes across a broad range of cell states and patterns with
the circulating biomolecule landscape to great depth. In the previous funding cycle, we were the first to apply
single cell genomics and large-scale multi-platform, multiomics of blood samples in severely injured patients.
This published work identified many novel findings, including the early massive release of cellular constituents
in trauma patients that follow a complicated course or die. In addition, open chromatin analysis of PBMC found
that patients who remain critically ill also have global epigenetic changes evident early across immune cell types,
representing de-repression of polycomb targets. In one line of research, we will reverse translate the these
and other dramatic findings from our initial human multiomic analyses into our mouse model of hemorrhagic
shock and trauma to pursue potential therapeutic targets. In another line of research, we will extend our
multiomic analysis to create a Blood Atlas of the human trauma response. This online resource will incorporate
data on the range of circulating immune cell states commonly seen after severe injury and integrate these with
the longitudinal changes in high dimensional datasets of circulating proteins, lipids and other metabolites. We
will apply state-of-the-art computational strategies to identify biomarkers and therapeutic targets with patients
stratified by outcomes, treatments, age and sex. We will compare our results with similar published studies in
sepsis. In addition to the discoveries and mechanistic insights our analysis will yield, we hope that the resources
we provide will stimulate comparative studies and further analyses of our datasets.
Research Strategy
Scientific Justification
Hemorrhage due to trauma-induced coagulopathy (TIC) is a key driver of mortality in severely-
injured patients. Coagulation phenotypes are dynamic post-injury, rapidly transitioning from an
anti-coagulant to pro-coagulant state (1). These states are highly dependent on a variety of
extrinsic variables such as dilution of blood with resuscitation fluids, environmental temperature,
and acidosis (2). The complex nature of the coagulation phenotype post-injury may be better
elucidated in a well-controlled animal model and we believe the studies outlined below will
provide important data regarding the role of cell death mechanisms in driving coagulation
phenotypes. Our extensive matrix of animal modeling studies provide an excellent opportunity
to characterize the role of these processes in driving TIC.
The proposed equipment purchase of a ROTEM delta (Werfen. Bedford, MA) will be used to
generate coagulation profiles of mouse plasma obtained using our hemorrhagic shock model.
We have proposed to use this animal model extensively in the parent R35, as it is the central
research which comprises Strategy 3, summarized below. Acquisition of this additional data
from plasma already in hand will bolster our already-extensive multi-omic analyses and move
our research in a novel direction by filling key gaps in our characterization of trauma
phenotypes. Adding a coagulation “-omics” component to our existing multi-omic workflow will
allow for mechanistic and correlation analysis not previously performed in trauma.
Strategy 3. Use of multi-platform, multi-omics to characterize the systemic response to injury
We will subject mice to severe (3 hour) and mild, resolving (1 hour) hemorrhagic shock
according to our standard model. Blood will be withdrawn at the appropriate endpoint using
cardiac puncture and divided into a heparinized tube for proteomic/metabolomic analysis and a
citrated tube for ROTEM analysis. Of note, studies will be performed on both male and female
mice in order to define the key differences in traumatic phenotypes associated with sex. The
treatment groups currently in progress or undergoing breeding crosses are outlined in the chart
below.
Animal model Pathway targeted male female mild severe
WT mice +
necrostatin Necroptosis x x x x
WT mice +
ferrostatin Ferroptosis x x x x
WT mice + Z-vad Apoptosis x x x x
PAD4-/- mice Netosis x x x x
Gasdermin D-/- mice Pyroptosis x x x x
Gasdermin D (fl/fl);
LysM-Cre+ mice
Pyroptosis in myeloid
cells x x x x
Gasdermin D (fl/fl);
Alb-Cre+ mice
Pyroptosis in liver
cells x x x x
Gasdermin D (fl/fl);
VE-Cre+ mice
Pyroptosis in
endothelial cells x x x x
Gasdermin D (fl/fl);
alphaMHC-Cre+
mice
Pyroptosis in
cardiomyocytes x x x x
Gasdermin D (fl/fl);
PF4-Cre+ mice
Pyroptosis in
megakaryocyte
lineage cells x x x x
Ninj1-/- mice Pyroptosis x x x x
Ninj1(fl/fl); LysM-
Cre+ mice
Pyroptosis in myeloid
cells x x x x
Ninj1(fl/fl); Alb-Cre+
mice
Pyroptosis in liver
cells x x x x
Ninj1(fl/fl); VE-Cre+
mice
Pyroptosis in
endothelial cells x x x x
Ninj1(fl/fl);
alphaMHC-Cre+
mice
Pyroptosis in
cardiomyocytes x x x x
Ninj1 (fl/fl); PF4-
Cre+ mice
Pyroptosis in
megakaryocyte
lineage cells x x x x
Original readouts proposed for mouse plasma: ALT/AST (Heska); metabolomic profiles
(Metabolon, Inc, Morrisville, NC); proteomic profiles (Creative Proteomics, Shirley, NY)
New data that can be added with proposed equipment: clotting time, clot formation time,
maximum clot firmness, alpha-angle, lysis index, and maximum lysis
Plans for future recurring costs
The requested instrument will require a service contract and consumable supplies. The Billiar
laboratory has access to other funding sources as well as robust Departmental support which
will guarantee coverage of the costs for service contracts as well as consumables for the term of
the parent R35 award.
Plans for equipment training and upkeep
The Department of Surgery research laboratories employ key technical staff members who are
responsible for instrument set-up, managing service contracts, and for performing weekly
maintenance checks. These technicians are trained by the company representatives and will
then train and new staff members who require use of the equipment. Product manuals and
technical representative contact information is kept with the instrument and available to all
users.
References
1. Klienveld DJ, Hamada SR, Sandroni C. Trauma-induced Coagulopathy. Intensive Care
Medicine; 2022 Nov;48(11):1642-1645.
2. White NJ. Mechanisms of Trauma-induced Coagulopathy. Hematology Am Soc Hematol
Educ Program; 2013 (1): 660-663.

Public health relevance
Project Narrative Trauma and surgical sepsis frequently lead to death and/or persistent critical illness, however there are no targeted therapies to improve outcomes. With advances in technologies, we can now measure changes in gene and protein expression in thousands of cells at the single cell level and at the same time measure levels of thousands of biomolecules in the circulation. We will continue to apply these technologies to the study of trauma and sepsis to identify predictive biomarkers and identify novel therapeutic targets.